Histoplasmosis Induction and Consolidation Therapy Factorial Randomized Clinical Trial (HISTO-FACT)

Abstract
Histoplasma capsulatum causes histoplasmosis, which is estimated to occur in ~500,000 persons per year in
the U.S. alone and is most common cause of HIV-related mortality in Central and South America. While many
cases are asymptomatic or mildly symptomatic, disseminated histoplasmosis (particularly in those with immune
compromise) leads to significant morbidity and mortality. Current therapy for moderate-severe histoplasmosis
consists of induction with daily liposomal amphotericin B (3mg/kg) for 2 weeks followed by at least 12 months
of itraconazole consolidation therapy. Despite these treatments, 6-month mortality remains ~25%. Further,
these toxic therapies commonly cause drug-drug interactions, kidney injury, electrolyte disturbances which can
lead to fatal cardiac arrythmias, liver toxicity and GI symptoms, which commonly cause early discontinuation.
Thus, there is a clear clinical need for improved therapies in moderate to severe histoplasmosis.
Our team led a phase II clinical trial comparing single high-dose (10mg/kg) liposomal amphotericin B to daily
standard dose liposomal amphotericin B for induction therapy in histoplasmosis and found similar efficacy but
improved safety in the experimental arm. Posaconazole has excellent in vitro activity against Histoplasma
capsulatum, case series’ showing good outcomes in a small number of human cases, and favorable tolerability
compared to itraconazole. Lastly, 12 months of consolidation therapy for people with HIV is a remnant from a
time when anti-retroviral therapy access and potency were poor – these have improved and six months may be
adequate with lower costs and toxicity for patients. We need a large phase III trial to answer these questions.
Our overall objective is to reduce morbidity and mortality due to moderate to severe histoplasmosis while
improving safety and tolerability of therapy through a phase III, factorial design clinical trial. Our aims are:
1. To assess the safety and efficacy of a single high-dose liposomal amphotericin B (10mg/kg) compared to
the standard of care (SOC) daily dosing (3mg/kg) for induction therapy in moderate to severe
histoplasmosis.
2. To assess the safety and efficacy posaconazole for consolidation therapy compared to SOC itraconazole
in moderate to severe histoplasmosis.
3. To assess the safety and efficacy of 6 months of consolidation therapy compared to the SOC 12 months
of consolidation therapy in persons with HIV on appropriate antiretroviral therapy.
This proposal has the potential to completely change every aspect of therapy for moderate to severe
histoplasmosis. If successful, this trial would lead to histoplasmosis therapies that are less toxic, more tolerable
and more affordable, translating to better outcomes in histoplasmosis and shorter hospitalizations. These
results would change WHO, PAHO and U.S. guidelines for histoplasmosis.

Public health relevance
Project Narrative Histoplasmosis is tied with tuberculosis as the most common opportunistic infection in Central and South America among people with HIV, and at least 500,000 cases occur in the U.S. yearly. Typical therapy for moderate severe histoplasmosis includes induction with daily liposomal amphotericin B (3mg/kg) followed by 12 months of itraconazole consolidation therapy; both therapies have high rates of toxicities and 2-week mortality remains at ~15%. A phase II trial showed improved toxicity and similar outcomes using a single high- dose (10mg/kg) of liposomal amphotericin B compared to the standard of care, and posaconazole is used as alternative in consolidation therapy, but with inadequate evidence; this large phase III trial will allow us to determine whether a single high-dose of liposomal amphotericin is non-inferior to the standard of care induction therapy, whether posaconazole is non-inferior (and if so, then, if it is superior) to the standard of care consolidation therapy, and whether 6 months, rather than 12 months, is an adequate duration of consolidation therapy for people with HIV on anti-retroviral therapy.